Preventing Firearm Suicide Deaths Among Black/African American Adults

PROJECT SUMMARY/ABSTRACT
This is a K18 award application for Dr. Evan Goldstein, an experienced health services researcher with
expertise in suicide and health care disparities research. The K18 will provide Dr. Goldstein with the support
necessary to expand his research program through new techniques and collaborations in three key career
enhancement areas: 1) Developing qualitative research skills to enrich his quantitative work; 2) Enhancing his
expertise in stakeholder engagement processes and community-engaged intervention development with
underserved and underrepresented populations, focusing on Black/African American (AA) communities; and 3)
Cultivating and strengthening his research leadership skills in community-engaged firearm suicide prevention
research. To achieve his goals, Dr. Goldstein has assembled an interdisciplinary mentorship team comprised
of Dr. Jennie Hill (Mentor), an expert in qualitative and community-engaged research, and Dr. Hilary Coon (Co-
Mentor), a senior scientist and recognized leader in suicide research. Three advisors join the mentorship team
(Drs. Eric Seiber, Adam Bress, and Laura Prater), providing additional expertise in firearm safety research,
racial/ethnic disparities, interventions with underserved populations, mixed-methods research, and leadership.
More than 1 in 2 Black/AA suicide deaths involve firearms, the most lethal suicide method. Dr.
Goldstein’s objectives are to identify the life situations specifically preceding firearm suicide deaths among
Black/AA adults and gather feedback from health professionals and community members on how health
systems can intervene to prevent firearm suicides in Black/AA communities. He proposes the following
Specific Aims: Aim 1) Identify circumstances preceding firearm suicide among Black/AA adults; Aim 2)
Conduct interviews with Black/AA firearm owners to better understand their attitudes on firearm safety and
their willingness to discuss firearm safety with health professionals; and Aim 3) Gather health professional
feedback on which circumstances preceding firearm suicide deaths could be used to adapt and prompt
Counseling on Access to Lethal Means (CALM) for Black/AA adult patients. This proposal will respond to NIH’s
call for researchers to identify risk factors and improve firearm suicide prevention in racial/ethnic minority
communities, specifically focusing on Black/AA adults.
The proposed research is significant because it will fill a critical need for determining key circumstances
preceding firearm suicide deaths among Black/AA adults and identifying potential intervention scenarios. The
proposed research is innovative because it will harness medical examiner/coroner and law enforcement report
information paired with community member and health professional interviews to generate information about
firearm safety and ways to make lethal means counseling more population-informed and effective for Black/AA
adult patients.

Public health relevance
PROJECT NARRATIVE More than 1 in 2 Black/African American suicide deaths involve firearms, the most lethal suicide method. Identifying the life situations specifically preceding firearm suicide deaths among Black/African American adults and gathering feedback from health professionals and community members on how health systems can intervene to prevent firearm suicides in Black/African American communities are critical steps toward developing population-informed and effective interventions to prevent firearm suicides.